Perceived Discrimination, Geography, and Demographic Effects on Immune Cell Function and Regulation

PROJECT SUMMARY – Project 2
Immune-mediated inflammatory diseases are a health burden for approximately seven percent of the
population of Western nations. Our preliminary data suggest variations in ethnic identity and/or geography
influence discrimination experiences and inflammatory response trends. This study investigates how
geography, ethnicity, and a laboratory manipulation of discrimination experiences affect immune cell
function and genomic regulation. Flow cytometry and immune cell challenges will test monocytes from
peripheral blood, and next-generation transcriptomics will assess genomic and epigenetic mechanisms.
We will test the hypothesis that geography, self-identified race, and ethnicity, interacting with
discrimination conditions, significantly affect immune cell function through genomic and
epigenetic mechanisms, with perceived discrimination as a moderating factor in immune cell
outcomes. The transdisciplinary nature of the proposed study will incorporate cutting edge behavioral,
epigenetic, and genomic techniques that can serve as a guide for other researchers interested uncovering
biopsychosocial mechanisms leading to poor health across diverse populations. The valuable insights on
differential susceptibility to immune-mediated inflammatory diseases that will be uncovered in this project
can inform feasible interventions for these diseases in different population groups.